Development and Randomized Clinical Trial of an App-based Intervention to Reduce Postpartum Depression in High-Risk Women

Postpartum depression (PPD) affects 1 in 7 mothers in the US with double the rate among
low-income women, causing emotional distress, consequences for infant development and later
child adjustment, disruptions in family relationships, and significant financial burden. The ROSE
Program (Reach Out, Stay Strong, Essentials for mothers of newborns) is an evidence-based
preventive intervention administered as a series of 4 in-person group sessions plus one
postpartum booster session. ROSE reduced cases of PPD by half in four clinical trials with low-
income women. However, there are major obstacles to disseminating ROSE broadly to women
at risk for PPD. If women across the nation could easily access ROSE virtually at the time and
place of their choosing, the incidence of PPD could be reduced significantly. Our Phase I project
developed a prototype of the first virtual ROSE session and we found 100% of 38 pregnant
women at risk for PPD who trialed the session rated their experiences as highly favorable,
informative, and helpful. Our current Phase II proposal goal is to finish development of a full
app-based ROSE program (e-ROSE) and evaluate the app’s outcomes to lay the groundwork
for commercialization and broad implementation. We know from previous trials that ROSE has
better outcomes than a control consisting of an educational brochure about PPD. We now
hypothesize e-ROSE and ROSE delivered as usual (ROSE) will result in better depression
outcomes compared to these historical control data. We also hypothesize e-ROSE will result in
a better return on investment (ROI) compared to ROSE and compared to utilization data from a
second control group of women who were not offered ROSE identified through electronic health
records. We will explore if depression outcomes for e-ROSE are non-inferior than for ROSE.
Last, we hypothesize that perceived access and satisfaction with the intervention will serve as
mediators of depression outcomes. Thus we will complete conversion of all five group sessions
to an app-based platform and incorporate additional engagement and support strategies (Aim
1), test its impact on reducing PPD and improving ROI within 3 months post-delivery in a
randomized trial (Aim 2), and determine if improving perceived access and satisfaction is a
pathway for improving depression (Aim 3). At the end of the project, the e-ROSE product will be
ready for Phase III commercialization nationwide allowing easy, low-cost distribution on a
variety of platforms to the end-users as well as position us for further research via
implementation studies.

Public health relevance
Postpartum depression can be prevented by the Reach Out, Stay Strong, Essentials for mothers of newborns (ROSE) evidence-based program yet continues to affect nearly 600,000 women and their families annually. Our goal is to help reduce rates of PPD by finishing development of a full app-based ROSE program (e-ROSE), evaluate the app’s outcomes for depression and return on investment, and determine if satisfaction and perceived access mediate outcomes. At the end of the project, the e-ROSE product will be ready for commercialization nationwide, allowing for easy, low-cost distribution on a variety of platforms to end-users, and we will have laid the groundwork for further research on implementation.